Examining the contributions of placebo effects in cognitive training

Project Summary/Abstract
This project addresses fundamental controversies regarding the extent to which benefits of cognitive training
may reflect, at least in part, placebo effects. Cognitive training is increasingly studied and applied as a potential
approach to enhance cognitive capabilities in healthy young-to-middle-age adults as well to ameliorate and/or
prevent age-related cognitive decline in individuals that may be at risk for developing ADRD. While extant data
suggest that well-designed cognitive training paradigms can produce positive real-world change in cognitive
functions, some researchers have suggested that the positive effects attributed to cognitive training may, in fact,
reflect placebo effects. This criticism stems from the fact that, in even the best designed cognitive training studies,
participants cannot be truly blinded to condition. While many cognitive training studies attempt to blind
participants to the intent or purpose of the training (e.g., using an inert control training that participants might
find plausible as an active intervention), because such control training experiences necessarily differ in key ways
from the active training experiences, it has nevertheless been suggested that participants in cognitive training
studies are able to intuit their condition and associated expectations and then show outcomes that are rooted
purely in these expectations. Despite this suggestion appearing frequently in commentaries over the past several
years, there exists little empirical work that directly addresses whether placebo effects may be at play in cognitive
training and whether such effects can be of a magnitude that explains previous results in the field. Here we
propose to overcome this fundamental gap in the field with a large-scale research study designed to explicitly
examine placebo effects in cognitive training. In particular, taking lessons from outside domains that have more
rigorously examined the induction of placebo effects, we utilize both “pure expectation” methods (i.e., verbally
telling participants that an inert training protocol will enhance their cognitive functions) and “associative
learning” methods (i.e., pairing training with subjectively experienced improved performance) in the attempt to
purposefully drive maximal amplitude placebo effects. This will not only serve to resolve the proximal
controversy regarding whether placebo effects in the domain, but if such effects are found, it will serve as a
benchmark for future research (e.g., to potentially harness such effects). We will examine how the size of such
effects may differ across age groups (younger and older adults), across cognitive domains (e.g., fluid intelligence,
working memory, selective attention), and across testing contexts (in-lab versus remote). Finally, as outside
domains have shown that there can be individual differences in the extent of placebo-responsiveness, we will
also examine a set of individual difference variables (e.g., personality) as possible moderators for these
differences. This research will provide a unique and foundational dataset that addresses directly and in a rigorous
manner the extent to which cognitive training effects can be explained by, and/or augmented by, placebos, and
inform future interventions addressing ADRD.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding the extent to which cognitive training is susceptible to placebo effects, and if so, whether such effects can be magnified/harnessed, would greatly aid the development and evaluation of treatment regimens for a host of disorders where deficits in cognitive function are amongst the core symptoms (e.g., ADRD in particular, as related to older adults, but also ADHD, schizophrenia, TBI, MCI, etc.). Thus, the proposed research cuts across the bounds of numerous NIH agencies, contributing to the missions of the NIA, NCI, NEI, NIMH, NIAAA, NINCD, NIDA, NINDS, in that all of these agencies work with populations who can gain direct benefits from successful approaches to mental fitness, and the NIH's greater mission to seek knowledge that will result enhanced health and a reduced burden of disabilities.